Protocol Review and Monitoring System

The Cancer Center Protocol Review and Monitoring System oversees and ensures the scientific merit, priorities, and progress of all cancer clinical studies conducted at the University of Virginia (UVA). A Protocol Review Committee (PRC), appointed by the UVA Cancer Center Director and administratively-supported by the Office for Clinical Research, has been given the authority and charge to carry out this mandate. The PRC is chaired by James Larner, MD. Its primary goal is to ensure that investigator- and industryinitiated cancer research studies involving human subjects conducted at the UVA Cancer Center are: (1) scientifically and statistically sound; (2) appropriately designed; (3) feasible for completion; and (4) in compliance with NIH guidelines for human studies. The PRC also plays an important role in mediating competing studies by requiring an agreed upon institutional prioritization plan, and closely monitors the accrual progress of studies.

Public health relevance
RELEVANCE (See instructions): The PRMS is responsible for assuring the scientific merit and regulatory compliance of all cancer clinical trials at the University of Virginia.